Targeting ferroptosis in aggressive subtypes of lung cancer

New therapeutic strategies are urgently needed to improve outcomes for patients with STK11/KEAP1 co-mutant
non-small cell lung cancer (NSCLC). We found that concurrent STK11/KEAP1 loss-of-function (LOF) predicts
poor (median overall survival of only 7.3 months) prognosis in NSCLC; compared to wildtype or single mutants.
STK11/KEAP1 LOF mutations dramatically enhance cell proliferation, invasive potential in vitro, and tumor
growth in xenograft lung cancer models. Furthermore, NSCLC cell lines harboring co-mutation of STK11 and
KEAP1 showed significant enrichment of pathways suppressing ferroptosis, and co-mutant cells were resistant
to ferroptosis-mediated death. CRISPR/Cas9-based screening of these cells identified synthetic lethal
interactions specific to the co-mutant state, including a crucial regulator of ferroptosis (SCD1). Our data suggest
that ferroptosis is a barrier to tumorigenesis in NSCLC and STK11/KEAP1 mutations provide multimodal
ferroptosis protection in co-mutant models. However, the underlying mechanisms of ferroptosis evasion, the
impact on immune microenvironment; and the effectiveness of targeting ferroptosis to overcome chemotherapy
and immunotherapy resistance in STK11/KEAP1 co-mutant NSCLCs still remain largely unexplored. Our
overarching hypothesis is that evasion of ferroptosis is critical to the survival and proliferation of STK11/KEAP1
co-mutant NSCLCs, and therapeutic regimens that induce ferroptosis and inhibit ferroptosis evasion could be
effective therapeutic strategy to overcome therapy resistance. Our objective is to delineate the mechanism and
establish ferroptosis as a potential target in STK11/KEAP1 co-mutant NSCLCs, with the long-term goal of
developing novel therapies for STK11/KEAP1 co-mutant NSCLCs. Aim 1 will define the molecular and immune
features associated with the progression or recalcitrance of STK11/KEAP1 co-mutant NSCLCs by (1)
determining the role on tumor growth, ferroptosis, metabolic landscape and immune microenvironment in
preclinical models; (3) determining the tumor heterogeneity and immune microenvironment changes associated
with the aggressiveness and recalcitrance of STK11/KEAP1 co-mutant NSCLC patient tumors. Aim 2 will
determine how STK11 and KEAP1 individually regulate invasion, tumor growth, and ferroptosis in preclinical
models. We will examine how selective loss of STK11 or KEAP1 affects downstream signaling, promotes
proliferation, invasion, ferroptosis evasion, and SCD1 expression in multiple in vivo models. Aim 3 will establish
the efficacy and strategy of targeting stearoyl CoA desaturase-1 (SCD1) [with ferroptosis inducers (FINs)] to
overcome resistance to chemotherapy or immunotherapy in STK11/KEAP1 co-mutant NSCLCs by (1)
determining the mechanisms by which SCD1 regulates tumor growth and survival in vivo; and (2) defining the
effectiveness of combining SCD1 inhibition (+/-FINs) to overcome chemotherapy and immunotherapy resistance.
Our study will have a significant impact on both our basic understanding of ferroptosis and our ability to target
SCD1 or ferroptosis in the most recalcitrant subset of NSCLC, directly supporting the mission of the NCI.

Public health relevance
PROJECT NARRATIVE There is an urgent need to develop novel therapies in STK11/KEAP1 co-mutant non-small cell lung cancer (NSCLC), a disease for which treatment options are extremely limited. We previously discovered that ferroptosis evasion gene programs are enhanced and that targeting ferroptosis regulators is a therapeutic opportunity in STK11/KEAP1 co-mutant NSCLC. We will (1) define the molecular and immune features associated with the progression or recalcitrance of STK11/KEAP1 co-mutant NSCLCs; (2) determining how STK11 and KEAP1 individually regulate invasion, tumor growth, and ferroptosis in preclinical models; and (3) establish the effectiveness of targeting stearoyl CoA desaturase-1 (SCD1), with or without ferroptosis inducers, to overcome resistance to chemotherapy or immunotherapy in STK11/KEAP1 co-mutant NSCLCs.